LeaRRN: the Learning Health Systems Rehabilitation Research Network

PROJECT SUMMARY
Given the growing complexity of healthcare, continued problems related to quality and cost, and a widely-
recognized 17-year evidence to practice gap, there is an urgent need for a rehabilitation resource center that
supports the conduct of learning health systems (LHS) rehabilitation research and develops LHS researchers
to advance the field of rehabilitation care. Brown University, the University of Pittsburgh (Pitt) and Boston
University (BU), together with health system/health organization partners, are combining expertise and
resources to create LeaRRN: the Learning Health Systems Rehabilitation Research Network. LeaRRN’s
mission is to improve the quality, outcomes and value of rehabilitation care by fostering stakeholder-partnered
research within and across LHSs. LeaRRN will build upon a well-established infrastructure and collaborative
relationships at Brown, Pitt, and BU; faculty expertise in health services research, implementation science,
stakeholder engagement, and informatics; and established and emerging partnerships with a diverse group of
LHSs. LeaRRN’s overarching objective is to establish a national resource network to advance stakeholder-
partnered, rehabilitation LHS research to improve quality of care, demonstrate value, and enhance patient and
system outcomes. LeaRRN will include training to promote seven core LHS research competencies, including
(1) using a system science approach, (2) asking meaningful questions, (3) applying appropriate research
methods, (4) capitalizing on informatics, (5) championing research ethics, (6) optimizing quality improvement
and implementation science, and (7) engagement, leadership and research management. LeaRNN will also
support research innovation by convening health system stakeholders to identify priority topics to address
through mentored collaborations (i.e., LHS Scholar opportunities and pilot studies). Finally, through techniques
development, we will assess the needs of the rehabilitation research community, prioritize and design our
resources and activities to respond to those needs, and evaluate our impact. LeaRRN’s specific aims are to: 1)
create a LHS Innovation Hub that partners researchers with healthcare systems and engages stakeholders,
including patients, providers, administrators, payers, and policymakers, to develop rehabilitation-focused LHS
research questions; 2) provide funding and methodological/technical support for LHS Scholars and Pilot Study
Awardees to transform research ideas into full-scale studies conducted in real-world practice; and 3) develop a
knowledge repository, tailor LHS resources for rehabilitation and disseminate materials to advance best
practices in rehabilitation LHS research. LeaRRN will serve as a resource and incubator for rehabilitation
researchers interested in LHS research. The knowledge repository, investigative experience, collaborations,
and evidence generated by LeaRRN will transform the delivery, quality, and outcomes of rehabilitation care.

Public health relevance
PROJECT NARRATIVE Brown University, the University of Pittsburgh and Boston University, together with 8 health system/health organization partners, are combining expertise and resources to create LeaRRN: the Learning Health Systems Rehabilitation Research Network. LeaRRN’s mission is to improve the quality, outcomes and value of rehabilitation care by fostering stakeholder-partnered research within and across learning health systems.